Developing computational methods to identify of endogenous substrates of E3 ubiquitin ligases and molecular glue degraders

Project Summary/ Abstract:
The E1-E2-E3 ligase cascade is responsible for tagging substrate proteins with ubiquitin. Addition of ubiquitin
then directs the tagged protein along one of several paths, including marking it for proteasome-mediated
degradation. The E3 ligase is responsible for recognition of substrate proteins, and thus encodes the specificity
of ubiquitin transfer. The human proteome comprises about 600 known E3 ligases, each with a distinct
substrate specificity that allows it to engage a prescribed subset of the proteome. Given that one of the
prototypical consequences of ubiquitination is to mark a protein for destruction, it is unsurprising that
dysregulation or mutation of E3 ligases can lead to a disruption of cellular homeostatic balance: accordingly,
E3 ligases have been implicated in a wide variety of diseases including autoimmune disease and cancer.
Intriguingly, certain disease-associated mutations have been found to alter the substrate specificity of an E3
ligase – these mutations not only impact the cellular levels of proteins within the E3’s normal interactome, but
rather they change the E3 ligase’s interactome. Similar effects have also been observed from certain small
molecules, termed molecular glues, that also modify the substrate specificity of an E3 ligase: these compounds
typically redirect an E3 ligase to ubiquitinate some “neo-substrate”, ultimately leading to degradation of this
protein. Thus, molecular glues afford the possibility of targeting disease-causing proteins that were previously
thought to be undruggable. To date, however, the transient nature of E3 ligase’s interactions with their
substrates (and neo-substrates) has served as a bottleneck for identifying both endogenous and “glue-able”
substrates of E3 ligases. To address this, here I propose to develop cutting-edge structure-based machine
learning methods to (1) computationally identify endogenous substrates of E3 ligases, and (2) rationally design
molecular glues that degrade a traditionally undruggable target protein. After carefully benchmarking the
underlying methods for each task, I will apply the former to comprehensively catalog substrates of three
specific disease-relevant E3 ligases. In parallel, I will apply my approach for the latter to design molecular
glues intended to degrade ADAR1, a key protein that promotes resistance to immune checkpoint blockade
therapy and is thus a potential target for intervention in many different cancers. Beyond the immediate scope of
this proposal, I anticipate that the methods developed through these studies will help illuminate the underlying
biology of many other E3 ligases, and will facilitate development of molecular glue degraders targeting key
drivers in many other diseases.

Public health relevance
Project Narrative: The substrate specificity of E3 ligases determines which proteins in a cell are targeted for degradation. Changes in substrate specificity can lead to disease (in the case of mutations) or enable potential treatments (in the case of pharmacological agents such as molecular glues). Here we propose novel computational approaches to identify endogenous substrates and to identify molecular glues that will target specific disease- causing proteins.